Reparative functions of human airspace macrophage subsets

PROJECT SUMMARY
For lung health to be restored after inflammation, dead cells must be removed from the airspaces and the alveolar
epithelium must be repaired. Airspace macrophages (AM) have been implicated in clearance of apoptotic cells,
termed efferocytosis, and in orchestrating epithelial repair. Whether all AM are capable of these functions, or
whether distinct subsets perform specialized roles following inflammation is poorly understood. In previous
studies, we leveraged an endobronchial lipopolysaccharide (LPS)-challenge model of acute lung inflammation
in healthy adults to obtain human AM and investigate their transcriptional signatures. Using single cell RNA
sequencing, we discovered that after exposure to LPS, the airspaces are dominated by recruited AM. These
recruited AM can be divided into two discrete subsets based, in part, on their efferocytic and reparative
signatures. However, the causal mechanism by which efferocytosis is linked to reparative programing of AM in
humans has not been established. The primary objective of this proposal is to identify the unique functions and
molecular drivers of AM subsets during resolution of inflammation and active lung repair. Based on analysis of
transcriptional signatures and our prior studies, we postulate that a subset of AM that closely resemble interstitial
macrophages (imAM) are characterized by two unique functions. First, we propose that imAM are uniquely
programed for efferocytosis. Second, we hypothesize that imAM drive repair of the alveolar epithelium through
production of paracrine signaling molecules. The proposed studies will independently test the dependence of
efferocytosis on driving these functions. We will use primary AM obtained from endobronchial LPS-challenge of
research participants and cutting-edge organotypic co-culture systems in the following three Specific Aims: 1)
Test the hypothesis that imAM are specialized for efferocytosis. 2) Test the hypothesis that imAM promote
alveolar epithelial repair. 3) Determine whether efferocytosis is required for reparative programing of human AM.

Public health relevance
PROJECT NARRATIVE Inflammatory lung diseases affect over 1 million individuals in the United States annually and are responsible for high mortality associated with respiratory infections. We believe that lung immune cells, called macrophages, are responsible for promoting repair of the injured lung. This study will help identify whether all macrophages, or specific subsets participate in repair and identify mechanisms that drive recovery from lung inflammation.